Regulation of mitochondrial health in mammalian livers.

Project Summary
Chronic liver diseases are common in the human population, including non-alcoholic fatty liver disease and
liver failure. These conditions are inherited or acquired due to a number of potential etiologies and can
progress to fibrosis, cirrhosis and hepatocellular carcinoma. Therapeutic strategies to limit the incidence and
progression of liver disease would be broadly applicable to affected individuals. A common observance in
humans and animal models with liver disease is accumulating mitochondrial electron transport chain (ETC)
dysfunction, which contributes to disease progression and pathophysiology. Our long-term objective is to
identify therapeutic opportunities which promote mitochondrial health in the mammalian liver. Our preliminary
data indicate that there are selective processes in animals and humans in vivo which promote the expansion
and proliferation of hepatocytes with functional mitochondria, centering around acetyl-CoA production and
protection from hepatotoxic challenges. Understanding the biology underlying this processes may provide an
opportunity to promote mitochondrial health in the liver. In Aim 1, we will examine the regulation of ETC health
in the liver under homeostatic conditions, making use of a collection of conditional knockout alleles in mice
which target each component of the mitochondrial ETC. In Aim 2, we will investigate how ETC health is
regulated in non-alcoholic fatty liver disease. In Aim 3, we will examine regulation of ETC health following
hepatotoxin challenges. In each aim, we will examine the underlying mechanisms as they relate to acetyl-CoA
production, which we have found to be a key metabolite regulating proliferation and survival of hepatocytes.
Together, these objectives will investigate mechanisms underlying the regulation of mitochondrial health in the
mammalian liver in multiple physiologic scenarios, and inform on therapeutic strategies to augment these
mechanisms and prevent progression of liver disease.

Public health relevance
Project Narrative Mitochondrial dysfunction is observed in common human diseases, including aging, nonalcoholic fatty liver disease and liver failure. Methods to promote mitochondrial health in the mammalian liver should ameliorate the prevalence and consequence and severity of these diseases. By characterizing mechanisms which regulate mitochondrial health in the liver, we will identify therapeutic opportunities to prevent the progression of liver disease in humans.